Defining the roles of mutant p53 and Mdm2 in metastasis

PROJECT SUMMARY
Tumor cell invasion and metastasis are ultimately critical determinants of cancer related mortality. Innovative
approaches are required to leverage biologically based mechanistic insights into the potential for new
translational biomarkers, prognostic stratification and therapeutics. Certainly, mutations in the tumor suppressor
TP53 are important in tumor initiation, microenvironmental landscaping and metastasis. Less is known about
the mechanisms of different TP53 mutations in fostering metastatic colonization and outgrowth. MDM2 is
important in the regulation of wild-type p53, but its role, along with its heterodimer MDMX, in the context of
mutant p53 or p53 null backgrounds, requires elucidation in metastasis biology. The overarching goal of this
Project is to elucidate the differential contributions of specific missense p53 contact and conformational
mutations and MDM2/X functions, independently or in concert, in tumor invasion and metastasis. We
hypothesize that different p53 mutations and MDM2/X will differentially contribute to metastatic abilities of tumor
cells. This hypothesis will be addressed by the following interrelated Specific Aims through the deep and
already existing interactions, and collaborations between the Prives and Rustgi labs at Columbia
University, using complementary in vitro and in vivo model systems: AIM 1. To elucidate the cell
autonomous mechanisms mediated by specific missense TP53 mutations that contribute to tumor cell invasion
and metastasis; AIM 2: To determine the effects of the extracellular matrix upon tumor cells with different
missense TP53 mutations upon invasion, as a prelude to metastasis; and AIM 3: To determine the p53-
independent roles of MDM2/X in tumor metastasis. Our project has specific interactions with Projects 1, 2 and
4 through sharing of conceptual frameworks, reagents, model systems and technical expertise, which promote
synergy. We will utilize the Cores that will accelerate our progress in achieving our vision.

Public health relevance
PROJECT NARRATIVE Tumor invasion and metastasis have a large impact upon cancer related mortality. Our innovative approaches to elucidate how p53 and MDM2/X proteins impact upon spread of tumor cells will pave the way for new perspectives on cancer detection and therapy.